CLINICAL TRIAL: LIOTHYRONINE (T3) STUDY FOR BIPOLAR DEPRESSION

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. It is a randomized double-blind study of Liothyronine (T3) Augmentation to Quetiapine vs Placebo Augmentation to Quetiapine For The Treatment of Bipolar Depression